Randomized trial of a data-driven technical assistance system for drug prevention coalitions

PROJECT SUMMARY
Summary/Abstract of Parent Award: The overall goal of this five-year R01 study is to test the Coalition Check-
Up (CCU) technical assistance (TA) system for supporting community coalitions' implementation of evidence-
based drug prevention programs (EBPs). Community coalitions are a cornerstone of federal drug prevention
policy but have only demonstrated efficacy in preventing substance use when they implement EBPs, a capacity
many lack. CCU TA supports coalitions in identifying and addressing gaps in their EBP implementation capacity.
The proposed study advances implementation science by applying Wandersman's Interactive Systems
Framework to test the effects of CCU on coalition EBP implementation capacity and youth outcomes. Despite
the popularity of drug prevention coalitions as a mechanism for EBP dissemination, there has been little research
on how to effectively support coalitions for optimal EBP implementation. Lacking adequate support, coalitions
and EBPs often fail, and TA as provided in evidence-based coalition models is often too expensive to scale in
real-world settings. The CCU provides a lower-cost TA system that is broadly applicable across coalition models.
Our main objective is to test the overall effectiveness of the CCU, including how it contributes to EBP
implementation and prevention of youth substance use. Building on the Interactive System Framework, our
central hypothesis is that the CCU, as part of the implementation support system, increases coalition capacity
for EBP implementation, thereby increasing the probability that EBPs will reduce youth substance use. We will
test this central hypothesis and our larger conceptual model by pursuing three specific aims. The first aim is to
estimate the impact of the CCU on coalition capacity. Coalitions will be randomly assigned to the CCU or a 'data
report without TA' condition to evaluate whether the CCU improves coalition capacity as measured by coalition
member reports of team processes, network composition, and collaborative structure. The second aim is to
estimate the impact of the CCU on the implementation of EBPs, including EBP reach, implementation quality,
and sustainability. The third aim is to estimate the impact of the CCU on youth substance use. The CCU is
innovative in its emphasis on proactive monitoring and data-driven TA, its use of motivational interviewing to
enhance coalition-driven action planning, and its examination of network structure to enhance coalition capacity.
The proposed study's contribution is highly significant because the field currently lacks clear evidence of the
effectiveness of a TA model applicable to the heterogeneous mix of drug prevention coalitions in operation. The
research will enhance community coalition ability to bridge the research to practice gap in drug prevention
programming. Results are expected to have a positive impact on the field by establishing the evidence-base for
a low-cost, data-driven, manualized TA model that identifies how to intervene with community coalitions to
support sustained implementation of evidence-based drug prevention programs and policies known to promote
community health. Our main objective is to test the overall effectiveness of the CCU, including how it contributes
to EBP implementation and prevention of youth substance use. Building on the Interactive System Framework,
our central hypothesis is that the CCU can enhance the prevention support system, thereby increasing coalition
capacity for EBP implementation and the probability that EBPs will reduce youth substance use. This research
will build the evidence-base for a scalable TA model, indicating how to intervene with community coalitions to
maximize EBP fidelity and sustainability.

Public health relevance
PROJECT NARRATIVE of Parent Award: The proposed research is relevant to public health because it tests an intervention designed to enhance drug prevention community coalition capacity and improve evidence-based drug prevention program implementation, thereby reducing youth drug use. Thus, the proposed research is relevant to the part of NIDA’s mission of ensuring the rapid and effective dissemination of research findings to significantly improve the prevention of drug abuse and addiction.